Molecular mechanisms enhancing lymphatic valve formation

Lymphedema is a chronic disease that is caused by a dysfunctional lymphatic vasculature, and can occur from
either genetic mutations or physical damage. The disease affects 3-5 million people in the US alone, and the
majority are cancer survivors who had lymph node removal surgery. There are no effective treatments for
lymphedema, nor any prevention strategies. Symptoms include severely swollen tissues due to adipose tissue
deposition and fibrosis, resulting in an impaired immune response and recurring infections in patients.
Numerous studies have established that chronic lymph stasis begets lymphedema. Impaired lymph flow in
mice causes the regression of lymphatic valves because constant flow-mediated signals are required for the
formation and ongoing maintenance of lymphatic valve leaflets. Further, forward lymph flow is maintained only
by regularly spaced intraluminal valves derived from lymphatic endothelial cells (LEC). Lymphangiography of
human patients with either congenital or acquired lymphedema is characterized by retrograde lymph flow,
which strongly implicates defective or regressing lymphatic valves as a causative factor. Thus, a significant
unmet need is to prevent lymphatic valve regression and/or stimulate lymphatic valve formation to treat
lymphedema. Surprisingly little is known about how valve-forming genes are activated in response to fluid
shear stress. We have identified the first transcription factor that acts as a repressor of lymphatic valve
formation, Foxo1, and show that genetic deletion of Foxo1 from LEC increases the number of lymphatic valves
significantly. Our data are the first to show that the ablation of any gene is capable of increasing the number of
morphologically normal lymphatic valves. Thus, inhibitors of the Foxo1 pathway represent highly valuable
pharmacologic targets to enhance valve formation. Our central hypothesis is that deletion of Foxo1 will
increase the number of lymphatic valves by upregulating known valve-forming genes and will restore valve
function in an animal model of lymphedema. This hypothesis will be tested by the following three aims: Aim 1
will determine the mechanisms by which loss of Foxo1 enhances lymphatic valve formation, Aim 2 will identify
Foxo1-associated signaling pathways that increase lymphatic valve formation, and Aim 3 will analyze the
function of lymphatic valves in healthy and lymphedematous mice lacking Foxo1. It is highly anticipated that
these aims will provide novel insights into the role of Foxo1 in regulating valve formation and function, which
will ultimately lead to the identification of a druggable target and innovative therapy to treat patients with
lymphedema by augmenting valve growth and function.

Public health relevance
PROJECT NARRATIVE Congenital gene mutations and lymph node removal surgery often cause dysfunctional lymphatic vessels that lead to a condition of pathological tissue swelling and fibrosis, called lymphedema. Lymph fluid in these patients flows backwards, which indicates that the valves in lymphatic vessels are defective or degenerate over time. This proposal will investigate the only mouse model of enhanced valve formation and will identify novel therapeutic targets to treat patients with lymphedema by augmenting lymphatic valve growth and function.